Control of Muscle Stem Cells to Enhance Regeneration

PROJECT SUMMARY
According to the most recent U.S. Census, the elderly population will more than double to 80 million,
encompassing 1 in 5 Americans by 2050. Aging is characterized by a decline in tissue function and regenerative
capacity. Sarcopenia, also known as age-dependent loss of skeletal muscle mass and strength, is a major public-
health problem that affects 15% of the elderly, leading to loss of mobility and diminished quality of life. Age-
related muscle loss is paralleled by a loss in the function of muscle stem cells (MuSCs), key players in muscle
homeostasis and regeneration. However, the mechanisms responsible for age-associated MuSC dysfunction
remain elusive. Two major barriers to gaining mechanistic insights into MuSC aging are (1) the heterogeneity of
the aged MuSC population, which renders standard bulk analysis ineffective, and (2) the lack of tools to resolve
this heterogeneity, underscoring the need for single-cell studies.
We previously demonstrated that aged MuSCs are a heterogeneous population comprised of functional
and dysfunctional subsets. This key observation suggests a therapeutic strategy to regenerate muscle - boosting
the activity of resilient functional MuSCs. Here we explore this possibility using a specific cell surface marker
and a series of innovative single-cell technologies required to resolve MuSC subsets. Our preliminary data iden-
tify CD47 as a cell surface marker whose expression level, not presence or absence, distinguishes functional
CD47lo and dysfunctional CD47hi MuSC subsets. Known widely as a receptor for SIRPα, CD47 is also a receptor
for thrombospondin-1 (THBS1). We found that CD47hi MuSCs accumulate in aged muscle and aberrantly ex-
press THBS1. We hypothesize that during aging the accumulation of CD47hi MuSCs impairs the proliferation of
CD47lo MuSCs through secretion of THBS1, hindering regeneration and contributing to sarcopenia. Here, our
specific aims are to (1) determine how CD47 signaling goes awry in aging, (2) elucidate how post-transcriptional
regulation of CD47 is altered during aging leading to the accumulation of dysfunctional CD47hi MuSCs, and (3)
determine the effects of aberrant THBS1 secretion in the aged MuSC niche on regeneration. We capitalize on
cutting-edge single-cell technologies, including multidimensional single-cell mass cytometry (CyTOF) and multi-
plexed tissue imaging (CO-Detection by indexing (CODEX)). These technologies allow us to track simultane-
ously 40+ distinct cell and signaling phenotypes in CD47lo and CD47hi MuSCs (CyTOF) and resolve how spatial
changes in the architecture of the multicellular niche lead to MuSC dysfunction in aging (CODEX). We combine
this knowledge with in vivo investigation of regenerative capacity and strength in aged mice. Finally, we perturb
CD47 signaling in vivo using blocking antibodies to surmount the regenerative deficits in aged mice. The pro-
posed analyses of newly identified aged MuSC subsets that can be prospectively isolated will provide fresh
mechanistic insights into aging and inform therapeutic strategies to augment endogenous muscle repair.

Public health relevance
PROJECT NARRATIVE Sarcopenia, the age-dependent loss of skeletal muscle mass and strength, is a major public-health problem that affects the elderly, leading to loss of mobility, long-term care institutionalization, and diminished quality of life. Muscle stem cells (MuSCs) are key drivers of muscle regeneration, and MuSC subpopulations exhibit considerable heterogeneity in their regenerative capacity, especially with aging. Here we will develop novel strategies to isolate, characterize and overcome the defects in the dysfunctional aged MuSC subset and the aged stem cell niche, informing potential therapeutics to improve skeletal muscle regeneration in the elderly.